Molecular Biology and Genetics of Human Tumor Viruses

PROJECT SUMMARY/ABSTRACT
Viruses cause approximately 15% of human cancers. A viral etiology to a human cancer can have substantive
consequences on its treatment and prevention. For example, many virally-caused human cancers express virally
encoded products, which are potential targets for anti-viral, tumor-specific therapies. In addition, unique sets of
cellular genes and pathways contribute to virally-associated cancers, many of which are currently being pursued
as targets for anti-cancer therapies. This program project grant (PPG) has two major objectives: to use molecular
biology and genetics to elucidate the life cycles of and transformation by human tumor viruses and to translate
this understanding into the identification of targets for specific anti-viral, anti-tumor therapies. We are focused on
studying human tumor viruses in three different virus families: papillomaviruses, Epstein Barr Virus, and Kaposi
Sarcoma Virus. Together, these three families of viruses cause many of the virally-associated human cancers.
This request for an Administrative Supplement to provide 5 months of bridge funding, until the competitive
renewal is funded in early 2024 is to support 4 of the 5 projects in the current PPG (the one project left out has
been sunsetted because Dr. Dan Loeb, Project Leader for Project 2, has retired). The goals of the four projects
are: Project 1) to identify and characterize cellular genes that drive human papillomavirus-associated cancer and
modulate viral infection; Project 3) to study the replication and inheritance of herpesviral genomes in relevant
cell types using novel approaches for live cell imaging; Project 4) to characterize cellular and viral factors that
regulate the switch from the latent to lytic viral state of Epstein Barr virus (EBV); and Project 5) to define drivers
of EBV- associated carcinogenesis and develop novel approaches for treating these cancers and diseases
caused by herpesviruses. There are three cores to this PPG that provide expertise in A) administration, statistics
and bioinformatics, B) instrumentation, microscopy and histology, and C) virus engineering and production.
These cores will be funded during this no cost extension period from institutional support as indicated in the
cover letter.

Public health relevance
PROJECT NARRATIVE Viruses contribute to at least 21 different human cancers, representing approximately 15% of all human cancers. Understanding how the biology of these human tumor viruses and how they cause cancer will provide new approaches for preventing and treating the associated cancers.